Reward Function in Adolescents with Depression and Cannabis Use

PROJECT SUMMARY/ABSTRACT
Adolescent depression and cannabis use are concurrent major public health concerns, and this comorbidity
has been associated with long-term cognitive and behavioral consequences. However, there has been sparse
research in this area, as most neuroimaging studies in adolescent depression exclude cannabis users. We seek
to address this gap based on converging evidence that: 1) Reward dysfunction contributes to maintenance and
progression of depression in adolescents; 2) Reward dysfunction is a heterogenous construct involving deficits
in diverse cognitive processes, including reward anticipation, attainment, and prediction error; 3) These deficits
entail distinct neural mechanisms that can be studied by functional magnetic resonance imaging (fMRI); 4) The
major psychoactive agent in cannabis, Δ9-tetrahydrocannabinol (THC), exerts its effects through modulation of
the cortico-striatal reward system; and 5) Cannabis use may result in temporary relief of mood and anxiety
symptoms while inducing potentially deleterious long-term neural reward alterations. We documented that
anhedonia–a core symptom of depression reflecting reward deficits–was associated with worse depression
outcomes, including chronicity and suicidality, in adolescents. Similarly, using resting-state fMRI, we found that
altered striatal intrinsic functional connectivity (iFC) with the prefrontal cortex was associated with anhedonia
severity in depressed adolescents. Further, using the reward flanker task (RFT), we found that adolescents with
diverse mood and anxiety symptoms showed weaker striatal activation during reward anticipation than healthy
controls, while stronger activation in the anterior cingulate cortex predicted worse higher levels of anhedonia at
two-year follow-up. We therefore propose a 2×2 cross-sectional study to test the overall hypothesis that comorbid
cannabis use in adolescent depression is associated with more severe neural reward deficits and clinical
symptoms. Participants will comprise 30 depressed cannabis users, 30 depressed cannabis non-users, 30 non-
depressed cannabis users, and 30 healthy controls, all ages 14-18 (Tanner stage ≥ 4) and psychotropic-
medication-free. Using resting-state and RFT task fMRI, we predict that comorbid cannabis use and depression
will be associated with more pronounced deficits in reward anticipation (Aim 1) and alterations in cortico-striatal
iFC (Aim 2) than depression alone. Further analyses (Exploratory Aims) will assess the relationships between
cannabis use frequency and activation during reward anticipation, cortico-striatal iFC, and symptom severity.

Public health relevance
PROJECT NARRATIVE Adolescent depression and cannabis use are concurrent major public health concerns, and both have been associated with long-term alterations in brain function and behavior. This research training fellowship utilizes non-invasive neuroimaging approaches to examine reward function in the co-occurrence of depression and cannabis use in adolescence, a critical and vulnerable period of brain development. By seeking to understand brain processes underlying these comorbid conditions early in life, this project has the potential to inform future preventive, diagnostic, and therapeutic strategies that may be employed in the care of this high-risk population.